Multidisciplinary Training Program in Lung Disease

Project Summary
The goal of this T32 program is to produce outstanding biomedical scientists who expand the envelope of our
knowledge of the mechanisms, manifestations, prevention, and cures of lung disease. The program combines
intensive training in a single area of investigation within a multidisciplinary academic environment. The training
is available at both the pre- and postdoctoral levels, supporting 2 predoctoral and 14 postdoctoral trainees per
year. A PhD program may be completed in 5 years. At the postdoctoral level, qualified MD, PhD or MD/PhD
candidates complete 2 or more years of training. A wide range of training opportunities are provided by a large
interactive network of faculty supported by individual, collaborative and inter-institutional research grants. These
opportunities include lung-related research in behavioral science, cellular and molecular biology, environmental
exposures, clinical trials, epidemiology, global health, immunology and infection, airway biology, sleep biology
and vascular biology and cellular metabolism. The core of the experience is the close relationship between a
primary mentor, co-mentors and the trainee and integration between bench researchers and physician scientists.
This is supplemented by individual development plans, formal course work, core conferences, training in
responsible research conduct, communication skills, career planning, and grant writing workshops. Postdoctoral
trainees in the clinical sciences can acquire a Masters or Doctoral degree. Trainees and mentors are reviewed
by committees that monitor the training and career development of students and fellows and promotes mentoring
skills. Doctoral students are additionally reviewed by a thesis committee that provides both support and
guidance. Over the last 20 years, for predoctoral graduates, 95% placed into research-intensive or research-
related positions in academia, government or industry, with 95% retention. For postdoctoral graduates, 80% of
graduates received 3 or more years of research training supported by this T32 and 93 individual fellowship
awards. 94% of graduates placed into full-time academic or research positions in government after graduation,
supported by 107 mentored early career awards (K-series and foundation awards). 87% of graduates remain in
academic or research-intensive or research-related positions in industry/government.

Public health relevance
Project Narrative Lung disease is a leading cause of death and disability in the United States. Despite an expanding understanding of the causes of lung disease, treatments that cure these disorders are lacking and most treatments are symptomatic or supportive. The goal of this program is to train highly qualified individuals in the research disciplines that are necessary to find better treatment and prevention of these disorders.